Understanding and exploiting apoptotic dysregulation in ovarian cancer

PROJECT SUMMARY/ABSTRACT
Death rates have decreased across many cancer types owing to improved early detection and treatment
methods, but remained largely stagnant for ovarian cancer over the last four decades. High grade serous
ovarian carcinoma (HGSOC) is the most common and deadly subtype, accounting for almost 70% of all
ovarian cancer cases and 70-80% of deaths. HGSOC likely develops from secretory cells of the fallopian tube
epithelium (FTE) and neoplastic transformation typically produces highly metastatic tumor cells that are p53
mutant and homologous recombination defective. Apoptosis (programmed cell death) is a fundamentally
important process for removing damaged and malignant cells and evasion of apoptosis is a hallmark of cancer.
The intrinsic apoptosis pathway is controlled by the BCL-2 family of proteins, which are often dysregulated in
cancer cells to confer a survival advantage. We have recently detected an upregulation of the BCL2L1 gene,
which encodes pro-survival protein BCL-XL, in HGSOC compared to normal fallopian tube epithelium. This
upregulation produces a dependency on this pro-survival protein that may be targeted therapeutically. For my
F31 research proposal, I hypothesize that HGSOC cells have increased pro-survival protein expression,
particularly BCL-XL, to buffer against the increased pro-apoptotic signaling that is associated with neoplastic
transformation, which can be therapeutically targeted to increase tumor cell death. I propose to test this in
three aims: 1) ascertain apoptotic regulation and pro-survival protein dependence in pre-malignant and
malignant stages of transformation; 2) use HGSOC patient derived xenograft (PDX) mouse models to assess
the efficacy of combining pro-survival protein targeting drugs with first-line chemotherapeutics to enhance
tumor cell death; and 3) elucidate how hormone and follicular fluid exposure affects apoptotic regulation in
fallopian tube epithelial cells in an air-liquid interface culture. The training plan for this proposal is designed to
give me the mentorship, experience and skillset needed to obtain a postdoctoral position and ultimately
transition into an independent research career working in the field of gynecological cancer biology. Being
mentored by my sponsors, Drs. Kristopher Sarosiek and David Christiani, and working with close collaborators
that specialize in ovarian cancer research will allow me to learn the necessary laboratory techniques and gain
subject matter expertise in apoptosis, ovarian carcinogenesis, cancer therapeutics and environmental health
as it relates to cancer risk. The Science Advisory and Career Mentoring committees that I have established will
provide further guidance in my growth as a successful, independent scientist. I will publish manuscripts and
attend conferences to present my findings and hone my written and verbal scientific communication.
Ultimately, this F31 will provide me with the training and expertise necessary for a career in cancer research
and potentially an opportunity to positively impact the lives of women diagnosed with ovarian cancer.

Public health relevance
PROJECT NARRATIVE The intrinsic (or mitochondrially mediated) apoptosis pathway is a fundamental cell death pathway that helps maintain tissue homeostasis and prevent neoplastic transformation. High grade serous ovarian carcinoma (HGSOC), the deadliest and most common subtype of ovarian cancer, is found to have dysregulated expression of the BCL-2 family proteins that control the intrinsic apoptosis pathway, which supports HGSOC tumor cell survival. Thus, we propose to investigate the origins of this apoptotic dysregulation and therapeutically target these proteins to increase tumor cell death and improve patient outcomes.